Neuroimaging to investigate mechanisms underlying changes in Intake of high energy dense foods and alcohol from pre to post bariatric surgery

PROJECT SUMMARY
Sleeve gastrectomy (SG) and Roux-en-Y gastric bypass (RYGB) are the most effective weight (wt) loss
procedures for severe obesity. Our lab recently showed decreased brain reward activation to high energy
dense (HED) vs low energy dense (LED) food cues following both SG and RYGB. The reward activation
changes, however, have not been correlated with changes in actual intake of HED or LED foods. There is also
recent concerning evidence of increased alcohol intake and new onset alcohol use disorder (AUD) by 2 y
postsurgery. Although there are overlapping neural reward pathways underlying food intake and alcohol use,
the mechanisms behind increased alcohol intake postsurgery remain unknown. There is, however, evidence of
more rapid alcohol absorption in both SG and RYGB, which could be a factor in increased alcohol intake.
Alcohol absorption, however, has not been studied over time postsurgery to link it to increased alcohol intake
or AUD. To investigate the neurobiological mechanisms, we will conduct a study of three groups of 70 each:
SG, RYGB, and a nontreatment (NT) group, matched for baseline BMI, sex, age, and alcohol intake, at
presurgery, 1 y (when body weight tends to stabilize), and 2 y postsurgery (when alcohol intake increases).
Although weight loss is similar for SG and RYGB, the surgeries differ anatomically, yet lead to similar
increased drinking, making them both worthwhile to study. Primary Aim 1: a) Determine neural responses to
visual cues of alcohol (ALC) and non-alcohol (NA) drinks as well as HED and LED foods. From pre to post
surgery, cue reactivity in 9 common reward ROIs to alcohol and food is expected to increase in response to
cues of ALC vs NA and decrease to HED vs LED. The changes are expected to manifest at 1 y and strengthen
at 2 y postsurgery. b) Relate changes in neural responses to ALC vs NA cues with changes in alcohol intake, #
AUD symptoms, and AUD status at 1 and 2 y. c) Test whether baseline reward activation to ALC vs NA cues
predicts increased postsurgical alcohol intake at 1 and 2 y. d) Compare for the above, the effects of (SG +
RYGB) vs NT (primary) and RYGB vs SG (secondary), expecting greater effects for RYGB than SG.
Primary Aim 2: a) Determine pharmacokinetics (PK) after 1 alcohol drink equivalent from blood alcohol
concentrations (BAC) at pre-drink, 2, 5, 15, 25, 35, 50, 65, 80 min post-drink. We expect that the surgical
groups will exhibit higher and sooner BAC peaks than NT, and that RYGB will result in higher and earlier peak
BAC than SG. b) Correlate changes in brain activation to ALC vs. NA cues in the common reward areas with
changes in BAC peak and time to peakpredict alcohol intake and AUD based on changes in BAC peak and
time to peak. The study results should enhance knowledge of neural mechanisms underlying the postsurgical
changes in alcohol and food intake, in association with changes in alcohol PK. This knowledge could lead to
development of new surgery procedures which do not lead to increased alcohol intake.

Public health relevance
PROJECT NARRATIVE Bariatric surgery is the most effective treatment for severe obesity but it confers elevated risk for increased alcohol intake and alcohol use disorder (AUD) following surgery. The brain mechanisms underlying decreased high calorie food intake and increased alcohol intake after bariatric surgery remain largely unexplored. To address these gaps in knowledge, we will examine changes in neural responses to food and alcohol cues as well as blood alcohol concentrations (BAC) to an alcohol challenge from presurgery to 1 and 2 years (when alcohol intake increases) after surgery.